PROTEIN BACKBONE STRUCTURE CHANGES THRU ACTIVE VALINE RESIDUES IN PHOTOREACTION

Evidence from x-ray, neutron diffraction and electron microscopy suggests that the Fhelix is tilted during the bR photocycle, opening the entrance of the SB region to protons and the G-helix of bR undergoes significant structural changes during the proton transport. Coincidently, 10 of the 21 valine residues in bR populate these two helices, 7 in F (Val 167, 173, 177, 179, 180, 187 and 188) and 3 in G (Va1210, 213, and 217). From Henderson's structural model for bR,681 there are two directly bonded valine-pairs (Vall79 and VaI180, VaI187 and VaI188) in the valine rich F-helix. In each of them, the carbonyls are close in space (-3 AO). The distances between the valine pairs VaI177 and VaI179 in F, A Va1210 and V11213, andVa1213 and Va1217 in G are about4.5 A to 5 Furthermore, the 13CCP/MAS NMR difference spectrum between the light-adapted (LA) state and M. photointermediate of [1-13CVal], [15N-Prol-bR shows that the chemical shifts of at least two of the 21 valine residues move upfield by at least 3.5 ppm, an indication of significant structural changes near these valine residues. This [unreadable]implies that these valine residues are active during the bR photocycle. Selective observation of valines 49, 69 and 199 by heteronucleaf-dipolar recoupling (REDOR) has eliminated the possibility that the three valine residues, which are not in either the F or G helices, are responsible for the changes observed in the NMR difference spectrum. Therefore, it is worthwhile to investigate if these changes occur on the valine residues in the F and G helices in the LA-+M. transition. Homonuclear dipolar recoupling (MELODRAMA) experiments were performed at a short mixing time in order to recouple only the two valine pairs located about 3 A apart and at longer mixing time to correlate the three valine pairs in the F and G helices, which are further separated. The results indicate that the G helix likely undergoes changes in the early M and ML states, due to its direct bonding to the retinal chromophore and the role of the SB counterion residue Asp212. These changes disappear during the M[.-~M[,, transition. However, the F helix is relatively inert to the photoreactions in the first half of the bR photocycle.